Mechanisms of cardioprotective Y RNA signaling in macrophages

PROJECT SUMMARY/ASTRACT
Myocardial infarction (MI) is an acute event that precipitates chronic cardiovascular disease. As such,
therapeutics that reduce infarct size have the potential to stem the tide of downstream cardiovascular diseases
including heart failure. To date, current strategies either alleviate symptoms or, at best, slow the progress of
disease progression. A major untapped potential lies in the vast and poorly understood world of small non-coding
RNA. A promising catalog for prospecting potentially therapeutic small RNAs is in the secretome of cells with
demonstrated tissue-reparative capacity. IMEX are EVs secreted by therapeutically-enhanced cardiac stromal
cells. One small non-coding RNA enriched in IMEX derives from the YRNA 4 gene and dubbed yREX3. Previous
work demonstrate that yREX3 triggers profound transcriptomic effects in monocyte-derived macrophages
compared to other cell types in the heart. Specifically, yREX3 methylates Pick1 expression and enhances their
ability to clear dead cells, a process called efferocytosis. In this proposal, we propose to dissect the mechanism
of yREX3 signaling macrophages to enhance efferocytosis and cardioprotection. In Aim 1, we will confirm the
signaling events by yREX3 in macrophages to enhance efferocytosis. In Aim 2, we will investigate the direct
contribution of macrophages on tissue healing. Finally, in Aim 3, we will investigate the indirect effects of yREX3-
primed macrophages in cardioprotection. Understanding the mechanism of action of therapeutic small RNAs (in
their target cells) would represent a significant step toward both mechanistic understanding and advance toward
curative treatment for MI.

Public health relevance
PROJECT NARRATIVE Myocardial infarction is a major unmet need and current therapeutic strategies fall short of reducing infarct size (a major determinant of chronic heart disease). Here, we propose to elucidate the mechanism of a tissue- reparative small non-coding RNA (dubbed yREX3) and its major signaling target cell type, circulating macrophages. Understanding the signaling of yREX3 in macrophages offers a new paradigm of drug discovery in the staid world of ischemic heart disease therapy.